Merging Computation and Experiment to Understand and Develop Asymmetric Open-Shell Radical Cross- Couplings

PROJECT SUMMARY/ABSTRACT
Despite advances in high-throughput screening methods leading to a surge in the discovery of catalytic
reactions, our knowledge of the molecular-level interactions in the rate- and selectivity-determining steps of
catalytic reactions involving highly unstable and reactive open-shell intermediates is rudimentary. These
knowledge gaps prevent control, suppression or enhancement, of competing reaction channels that can drive
development of new catalytic reactions. Built on strong computational and experimental preliminary results, this
program seeks to understand and guide design of new sustainable, catalytic, and asymmetric transformations.
Overall, our goals are to develop predictive models of reactivity and selectivity of first-row, open-shell
transition metal-catalyzed carbon-carbon bond formations that can be adapted by the organic, organometallic,
and bio(in)organic community in the synthesis of medicinally-active compounds. To accomplish this
overarching goal, we have identified two areas of research for the next 5 years and plans for beyond. In the
first area, we will use combined experimental and computational tools to understand and develop new
asymmetric iron-catalyzed radical cascade/cross-coupling reactions. In the second area, through collaborative
efforts, we will target the synthesis of quaternary centers via metallophotoredox-catalyzed cross-couplings.
These reactions proceed through carbon-centered radical intermediates, open-shell organometallic species,
and photoexcited electronic state species where evaluating the mechanisms has been historically hampered
by the inherent complexity associated with the high reactivity and instability of these species. High-level
quantum mechanical calculations, rigorously calibrated against experimental data, will be used to interrogate
the mechanisms and to guide the development of new catalysts and reagents for currently sluggish or
unselective reactions. In addition, we will exploit selected potential energy surfaces susceptible to dynamic
effects, single-electron transfers, and intersystem crossings to gain a deeper understanding of the factors
determining product selectivity and inform catalyst and reaction design. Overall, these efforts will push the
limits of accurate molecular modeling of increasing complex catalytic reactions and potentially impact the fields
of organic, bio(in)organic, and transition-metal catalysis.

Public health relevance
PROJECT NARRATIVE This proposal will use high-level calculations and experiments to improve our knowledge of the factors controlling reactivity and selectivity and to develop new sustainable catalytic reactions. New reagents, catalysts, and chemical reactions are expected to provide rapid access to untapped chemical space and synthesis of compounds with desirable properties for applications to human health.